Sex Chromosome Aneuploidies in Autoimmune Disease

Abstract
Systemic lupus erythematosus (SLE) and Sjögren’s syndrome (SS) are chronic, inflammatory, autoimmune
diseases. Some features of these illnesses are similar. These include aspects of clinical manifestations,
serology and epidemiology. Most critical for this proposal is that there is a strong female bias found for both
diseases such that at least 90% of patients are women. The mechanism for this sex bias was unexplained
until the work of the PI, which began more than a decade ago and was funded in part by this VA Merit Review
for which a renewal is sought. The PI and his colleagues found that men with 47,XXY (Klinefelter’s syndrome)
are at the same risk of SLE or SS as women. In addition, 47,XXX women are at increased risk of either
disease compared to women carrying a 46,XX chromosomal complement. This X chromosome dose effect
was found for SLE and SS but not rheumatoid arthritis, primary biliary cirrhosis or sarcoidosis. Thus, our data
indicate multiple molecular pathways to female-biased disease. In cells with more than one X chromosome, all
but one undergoes X inactivation. However, X inactivation in humans is not an all-or-none process such that
up to 15% of genes on the X chromosome escape inactivation. That is, these genes are transcribed and
translated from both X chromosomes (biallelically) in normal (46,XX) women. We have identified two X
chromosomes genes that escape X inactivation in immune cells and are both involved in toll like receptor
(TLR) 7 signaling to produce interferon, and have a lupus risk allele identified in genome-wide association
studies. Namely, these genes are TLR7 itself and CXorf21. The protein product of CXorf21 physically
interacts with the protein product of another lupus risk gene – SLC15a4. In studies performed in the previous
cycle of this award, and published in 2019, we find that CXorf21 and SLC15a4 regulate endolysosomal pH and
are critical for TLR7 signaling. Knockdown of CXorf21 by CRISPR-Cas9 raises endolysosomal pH (less
conducive to TLR7 signaling), and impairs TLR7 signaling with marked reduction of interferon as well as other
cytokine production (see Progress Report and Preliminary Data). Of course, interferon production through
TLR7 signaling is known to be a critical aspect of lupus pathogenesis in both human and murine lupus. Thus,
these data constitute a strong premise for the work proposed herein. Much of the genetics of SLE has not
been identified by GWAS, and much of this missing genetics may be related to presently unidentified genetic
synergism. In the first aim, we will determine the degree of genetic synergism found in the interaction of the
lupus-associated alleles of these genes involved in the TLR7 pathway. This aim will use our cohort of >300
men with SLE, the largest cohort ever assembled by more than 3-fold. In the second aim, we will define the
physiological roles of the protein products of these genes in the TLR signaling pathway with particular attention
to the associated alleles using cutting edge molecular techniques. The final aim we will approach precision
medicine by studying the role of these genes in determining the efficacy of hydroxychloroquine. Since the
genes and hydroxychloroquine are involved in TLR7 signaling and lysosomal pH, we hypothesize that the
associated alleles will reduce the efficacy. This aim will utilize a unique resource of SLE patients on
hydroxychloroquine and followed for flare. Thus, these related but independent aims will advance the science
of the X chromosome gene dose effect that explains much of the sex bias of SLE and SS.

Public health relevance
Systemic lupus erythematosus, or simply lupus, is a chronic disease in which the immune system can attack any organ. More than 90% of patients are women. Our research is investigating why lupus has a predilection for women. Men should have one X and women should have 2. However, our work shows that men with 2 X chromosomes are at the same lupus risk as women, and women with 3 are at an even higher risk for lupus. So, we think that the risk of lupus is related to the number of X chromosomes, not sex. Furthermore, we have identified several genes on the X chromosome that we think may mediate this X chromosome dose effect. This proposal will determine the role of these genes in lupus and the sex bias of the disease. Lupus is a common illness among otherwise healthy young adults. Thus, lupus is frequently diagnosed among military personnel and leads to a medical discharge in most individuals. There are more than 10,000 patients cared for by the VA who are diagnosed with lupus.